Torsional stiffness and user preference: lower limb amputee lab test

? DESCRIPTION (provided by applicant): Project Summary (Public Abstract) The violent conflict of war always results in amputees. After World War II, a team of well-known clinician scientists led by H. D. Eberhart examined the biomechanics of human gait and reported to the National Research Council Committee on Artificial Limbs, advisory to the Veterans Affairs and the Office of the Surgeon General of the United States Army, that transverse plane motions and their frictional effects are a major source of discomfort and the chief cause of dissolution of the skin in lower limb amputees. This was quite remarkable given the state-of-the-art of prosthetic limbs in 1947. Identifying a problem is one thing, solving it is another. Thirty years went by before Lamoureux and Radcliffe reported in 1977 that a greater degree of freedom in the transverse plane of the prosthesis might improve the changing of direction of ambulatory amputees. As our own research suggests that turning maneuvers comprise about 30% of daily steps, it is not too surprising that evidence in the literature reports the benefits of commercially-available torsion adapters to include improved walking performance, reduced metabolic costs, the potential to reduce residual limb soft tissue injuries, and improved balance and stability. While these devices are available for prescription, a glaring problem remains. None of the commercially-available transverse plane torsion adapters can be adjusted by the user. When patients are fit with these devices, the prosthetist sets the stiffness and that is it. The selected stiffness is expected to be adequate for all of an amputee's activities. To address this deficiency, we developed a novel prosthesis whose transverse plane stiffness can be adjusted by the user. The specific aims of the proposed research are to determine: (1) the preferred transverse plane stiffness and (2) the transverse plane stiffness that minimizes the transverse plane moment applied to the residual limb of Veteran lower limb amputees during different ambulatory activities at different speeds. We believe this research will significantly improve the function and quality of life of Veteran lower limb amputees. Developing new technology that allows the prosthetic limbs of Veteran amputees perform like a natural limb is where the VA should be: at the forefront of prosthetic technology and prescription practice.

Public health relevance
PUBLIC HEALTH RELEVANCE Project Narrative (relevance to Veterans) Between 3000 and 5000 lower limb amputation surgeries are performed each year on Veterans [1]. These Veterans are among the 623,000 Americans who live with a major lower limb amputation (i.e., excluding toes) [2]. Further, U.S. involvement in the decade-long conflicts in the Middle East are resulting in additional amputees of traumatic etiology (n=1795 from 2000 to 2011), a population who will rely on the VA for many years to come [3]. Ambulatory individuals turn and maneuver throughout their daily activities [4, 5] but lower limb prostheses are only optimized for straight line walking. This project seeks to improve the ability of Veteran lower limb amputees to turn and maneuver by discovering the preferred torsional stiffness of a novel prosthetic limb. The clinical significance of the proposed research is the development of a prosthesis that can anticipate the ambulatory activities of lower limb amputees and optimize its properties for both performance and comfort.